Biomechanics Contributions to Symptoms and Joint Health in Individuals with Rotator Cuff Tears

PROJECT SUMMARY
A critical gap in rotator cuff tear research is understanding why some individuals have a torn rotator cuff but are
free of symptoms, while others experience pain and dysfunction. Dr. Pozzi’s Katz R01 (parent project,
AR080058) approaches this problem by examining the neural and somatosensory aspects (neuroimaging,
central sensitization, psychosocial distress) of symptoms in well-characterized cohorts of symptomatic tears,
asymptomatic tears, and healthy controls (no tears, no pain). We have a unique window of opportunity to submit
an ancillary project that evaluates the musculoskeletal aspects of symptoms, specifically neuromuscular control
and glenohumeral joint health, in the same cohorts as the parent project. The high prevalence of individuals with
asymptomatic rotator cuff tears as well as the success of some conservative exercise interventions for
symptomatic tears suggests neuromuscular control strategies can mitigate symptoms. However, since the
anatomical integrity of the torn tendon is not restored, to what extent previously identified changes of
neuromuscular control are adaptive versus pathological remains unknown. Current investigation on the
interaction between rotator cuff tears and glenohumeral joint health are limited to murine models, radiographic
imaging studies, and studies characterizing end-stage disease (i.e., co-presence of massive tears and
glenohumeral osteoarthritis). We will advance this prior work through three aims. In Aim 1, we will elucidate the
interrelationship between neuromuscular control and symptom expression in individuals with rotator cuff tears
by simultaneously measuring shoulder motion (including scapular motion) and electromyography (EMG) of
shoulder muscles (including intramuscular EMG of rotator cuff muscles) during functional tasks. In Aim 2, we will
elucidate the interrelationship between neuromuscular control, symptom expression, and shoulder joint health
in individuals with rotator cuff tear using static (magnetic resonance imaging to characterize cartilage) and
dynamic (musculoskeletal simulations to calculate glenohumeral joint forces) measures. In Aim 3, we will explore
potential treatment targets by leveraging recent advances in explainable artificial intelligence to evaluate the
relative contributions of various organ systems to rotator cuff symptoms. The organ systems evaluated in the
parent (nervous and somatosensory systems) and ancillary (musculoskeletal system) projects will be explicitly
studied. Completing this ancillary project will advance our knowledge of the musculoskeletal factors that
influence patient outcomes. Integrated analyses of the musculoskeletal (ancillary), neural (parent), and
somatosensory (parent) contributions to symptom expression will further elucidate the biological mechanisms
driving outcomes, thereby aiding the identification of rotator cuff tear phenotypes and treatment targets.

Public health relevance
PROJECT NARRATIVE The proposed ancillary project will evaluate how musculoskeletal biomechanics influences rotator cuff tear symptoms. We will use a combination of experimental and computational methods to examine neuromuscular control and glenohumeral joint health in individuals with symptomatic rotator cuff tears, individuals with asymptomatic rotator cuff tears, and healthy controls (no tears, no pain). Then, through integrated analyses of findings from the ancillary and parent projects, we will elucidate biological mechanisms driving symptoms, thereby aiding identification of rotator cuff phenotypes and treatment targets.